The nose-lung cross talk in upper respiratory virus infection induced asthma exacerbations

Project Summary
Upper respiratory virus infection (URVI) is the leading cause of asthma exacerbation episodes. The underlying
immunologic mechanisms are poorly understood. Particularly, it remains unknown if URVI-induced asthma
exacerbation is exclusively a result of direct viral infection in the lower airway and lungs, in the nose and upper
airway, or both. Previous study has shown that the viruses commonly associated with asthma attacks were not
detected in the lungs of patients who died of asthma attacks. Recently, we observed that nasal virus infection
can remotely activate lung immunity without direct lung antigenic exposure. Nasal viral infection can recruit
antigen presenting cells (APCs) in the lungs. These activated APCs ingest antigen and migrate to pulmonary
lymph nodes, enhancing both innate and adaptive immunity to unrelated antigens in the lungs. Our data have
suggested that nasal mucosa can remotely regulate lung immunity without direct lung antigenic exposure (aka
“nose-lung cross talk”). Such nose-lung cross talk may also play a key role in URVI induced asthma
exacerbations. In the proposed study, we will 1) define the immune mechanisms underlying the nose-lung
cross talk after nasal viral infection; 2) determine the airway physiology airway inflammation after nasal viral
infection in mice with experimental asthma and the mechanisms by which URVI indued asthma exacerbations.
Completion of this project is expected to advance our understanding of the mechanisms underlying URVI
induced asthma exacerbations, and to identify new preventative and therapeutic strategies for asthmatics. It
will also further define airway mucosal immunology, particularly the immune network underlying the nose-lung
cross talk, and to facilitate novel directions in nasal vaccine development and immunotherapy for diseases that
affect both the nose and lungs.

Public health relevance
Upper respiratory virus infection (URVI) is responsible for 80% of asthma attacks; however, the underlying mechanisms remain poorly understood. This project is proposed to dissect the cellular and molecular mechanisms undelying the nose -lung cross talk, particularly how URVI causes asthma attacks. Findings from this research are expected to lead to not only novel preventive and therapeutic strategies for asthmatics, but also to define nasal mucosal immune system and subsequently facilitate nasal vaccine development against airborne pathogens. OMB No. 0925-0001/0002 (Rev. 01/18 Approved Through 03/31/2020) Page Continuation Format Page